Mechanophenotyping RBC subpopulations in ME/CFS

ABSTRACT
Myalgic encephalomyelitis, also known as chronic fatigue syndrome (ME/CFS), afflicts up to 2.5 million
in the United States and millions more worldwide. Very little is known about its cause(s), most physicians are
not adept at diagnosis, and no biological markers or approved treatments are available. ME/CFS is a
heterogeneous and unpredictable disease with subsets of shared symptoms but most patients experience
post-exertional malaise, orthostatic intolerance, and cognitive disturbances. Plasma inflammatory and oxidative
stresses are increased in a subset of patients suggesting a multisystemic dyshomeostasis. Studies suggest
that impaired oxygen delivery to the muscles during high metabolic demand may explain the symptoms
common to most patients. Red blood cell (RBC) deformability is vital to microvascular oxygenation. We have
observed that the deformability of RBC in ME/CFS patients is lower than that of healthy subjects, due to an
increase in stiffer subpopulation of RBC in the patients. In this proposal, we will test the hypothesis that the
deformability distribution in RBC can serve to differentiate ME/CFS patients from healthy subjects, and that the
increased oxidative stress contributes to altered deformability distributions. We will implement an ultra-high
throughput microfluidic fractionator to sort RBC based on their deformability, and in the sorted subpopulations,
examine metabolic, structural, and functional changes. We will develop machine learning models to correlate
the biophysical and biochemical properties of the RBC subpopulations with the clinical measures to classify
ME/CFS into subtypes. Several undergraduate and master's students will actively engage at every stage of the
project, and will receive rigorous training in interdisciplinary research of high clinical significance.

Public health relevance
PROJECT NARRATIVE Myalgic encephalomyelitis, also known as chronic fatigue syndrome (ME/CFS), afflicts up to 2.5 million in the United States, and millions more worldwide; yet very little is known about its cause(s), and no biological diagnosis or approved treatments are available. Symptoms of ME/CFS suggest compromised blood flow through the blood vessels, and impaired oxygenation of tissues. Changes in the deformability of red blood cell (RBC) may contribute to a subgroup of symptoms, and understanding these changes in relation to the oxidative stress noticed in the patients, offers an opportunity for diagnosis, treatment and/or a better care for ME/CFS patients.